A health-literacy module for overweight adolescents and their parents on canine physical activity, nutrition and behavior: Enhancing DHHS'BodyWorks program at a Federally Qualified Health Center

ABSTRACT
The parent grant’s scope is to establish feasibility and acceptability of a novel approach to increase
overweight / obese adolescents’ physical activity by leveraging their attachment to the family dogs; and to
collect pilot data to establish the effect size of an empirically validated BodyWorks program (Borden et al.,
2012; DHHS, 2013) enhanced with a Canine Health Literacy module that parallels the BodyWorks humans -
only curriculum. The theory of change links an increase in the adolescents’ health literacy about both human
and canine physical activity and nutritional needs to more positive affect in the presence of the dog during
physical activity (Liao et al., 2017), which is expected to lead to an increase in physical activity.
The scope of the proposed administrative supplement remains the same as in the parent grant, however,
the population will be broadened to include both public and private insurance patients receiving care in
specialty clinics at Children’s Hospital Los Angeles (CHLA) and in CHLA-affiliated general pediatrics and
specialty community clinics. In the parent grant, only publicly insured patients receiving healthcare at the
FQHC AltaMed clinics in the CHLA geographical area have been included in the project, which limited
recruitment already disrupted by the COVID-19 pandemic. Specifically, the funding will allow to add
17 additional clinics, extending recruitment beyond the 5 FQHC AltaMed clinics to a total of 22
recruitment sites. The aims of the study are: Specific Aim 1: Test the feasibility and acceptability of a
concurrent approach using physical activity trackers and Ecological Momentary Assessment. 2(a): Test the
feasibility and acceptability of objective measurement of physical activity using wireless fitness trackers for
adolescents (FitBit Ace), their parents (FitBit Flex2), and their dogs (FitBark); 2(b): Test the feasibility and
acceptability of using mobile phones for Ecological Momentary Assessment of types and contexts of
adolescent's physical activity with dogs. Specific Aim 2: To establish the size of the effect, and the variability
associated with the 7 week-long BW + CHL module, as compared with the control group who received the
standard BW program in 3(a) adolescents' positive affect during or after physical activity with the dog, as
measured by the Ecological Momentary Assessment using prompts on mobile phones; and 3(b) levels of
overall physical activity for the adolescents, their parents, and the dogs as measured by the FitBit Ace
(adolescents), FitBit Flex2 (parents), and FitBark (dogs). The project will establish feasibility, acceptability,
attrition, and protocol compliance, and will collect pilot data needed for power calculations in preparation for an
R01 Randomized Controlled Trial as a next step to test the effectiveness of our enhanced BW+CHL program.
This project represents a significant methodological and theoretical advancement in the field of Human-Animal
Interaction (HAI) and in research on overweight and obesity.

Public health relevance
PROJECT NARRATIVE This Administrative Supplement requests funding for additional recruitment to develop and test a novel approach to design a Canine Health-Literacy module to enhance a Comprehensive Family Lifestyle Intervention BodyWorks, for dog-owning adolescents who have been diagnosed with overweight or obesity, and their parents. The results are anticipated to make an important step towards addressing the overweight and obesity epidemic among both people and companion dogs in the U.S.